Post-transcriptional Gene Regulation by EBV SM Protein.

Project Summary/Abstract
The broad, long term objectives of this project are to understand the control of human herpesvirus replication
and reactivation from latency. Epstein Barr virus (EBV) is a ubiquitous herpesvirus associated with human
lymphoid and epithelial malignancies. Lytic replication and expression of lytic gene products during virus
reactivation play an important role in pathogenesis. The focus of this application is to investigate the
mechanisms of action of SM, an EBV protein that is expressed during lytic replication and is essential for
production of infectious virus. SM binds to RNA and enhances expression of several EBV lytic genes including
those critical for capsid formation and infectivity. We have shown that these effects are gene-specific and that
SM is preferentially required for expression of a subset of EBV genes. A fundamental question is how SM
specifically facilitates expression of the mRNAs of these target genes. While SM stabilizes some target RNAs,
and has long been thought to only act post-transcriptionally, we provide new evidence that it also facilitates
EBV gene transcription. Identifying the targets of these separate mechanisms will allow a molecular dissection
of each function. A high throughput screening assay to identify SM inhibitors showed that spironolactone
(SPR), a clinically approved mineralocorticoid-blocking agent, has potent anti-SM and antiviral properties. We
have found that SPR acts to destabilize a cellular transcription factor, XPB which appears to be uniquely
involved in EBV gene transcription. SPR is therefore hypothesized to act through effects on host cell
transcription factors that are necessary for SM function. The project has three specific aims. The first is to
determine whether SM facilitates transcription initiation/elongation or RNA stabilization to achieve its
effects on each of its specific targets. We hypothesize that the combined effect of SM on transcription and
mRNA stability of individual genes varies based on specific target gene characteristics. By defining which
promoters SM affects, and which RNAs it stabilizes, the mechanisms of transcriptional and post-transcriptional
enhancement will be separated and individually investigated. The second aim is to investigate the
mechanisms by which spironolactone (SPR) inhibits SM function and to expand its utility as an
antiviral agent. Using a synthetic chemistry approach, the mineralocorticoid blocking activity will be ablated
from SPR, to demonstrate that it can be separated from antiviral activity. SPR derivatives will also be made to
identify its target proteins that will then be identified by proteomic techniques. In the third aim, the unique
role of XPB in EBV transcriptional initiation and elongation and its cooperation with SM will be
investigated. The combination of these three aims will not only clarify the mechanism of action of SM but will
lay the basis for targeting unique interaction points of viral and cellular gene expression for drug development.

Public health relevance
This proposal is to study growth of Epstein Barr virus, or EBV, a virus that is associated with cancer. The project will study a protein know as EBV SM that is essential for producing infectious virus. The project is also aimed at developing drugs that can block replication by inhibiting this protein.